DISSOCIATION OF HEPATOBILIARY MRI CONTRAST AGENT

These experiments assessed and quantitated the release of free manganese Mn (II)from the hepato-biliary contrast agent Mn-DPDP (Mn-dipyridoxal diphosphate), us ing several magnetic resonance techniques (EPR spectroscopy, 31P-NMR spectroscopy, and relaxometry) to differentiate between free and complexed Mn(II) in various preparations. The presence of calcium and magnesium in physiological concentrations in aqueous solutions induced the release of Mn2+ from the complex, as did incubation of the complex in liver homogenates. After intravenous injection of 15 fmol/kg of Mn-DPDP, both EPR and 31P-NMR spectroscopy demonstrated that Mn-DPDP is partly dissociated (approximately 25%) in the liver. By comparing in vitro and ex-vivo data from the liver, we concluded that the dissociation of Mn-DPDP occurs mainly in the liver, while a minor portion of the dissociated Mn found in the liver comes from dissociation of the complex in the blood. Most of the dissociated Mn in liver becomes bound to macromolecules and is responsible for the enhancement of relaxivity observed with this agent.